Public Insurance Design and Health at Older Ages

PROJECT ABSTRACT
Health insurance has been at the forefront of US public policy debate throughout the last decade. For elderly
Americans, who benefit from nearly universal coverage under Medicare, decisions about the scope of their
insurance coverage have been a central policy concern since Medicare’s inception in 1965. Medicare’s coverage
is extensive, but by statute the program only covers medical services that are “reasonable and necessary,” which
can be a controversial definition. Some decisions about what Medicare should cover have engendered intense
debate, underscoring the importance of the program’s coverage decisions for millions of patients and doctors.
The debate around the scope of Medicare coverage is likely to intensify in the coming decades as options for
medical treatment, and testing, expand rapidly, the population ages, and public insurance systems grapple with
how to address inequality in access to medical innovations. Yet, despite the importance of decisions about the
scope of insurance coverage in and outside of Medicare, we know little about how the scope of coverage (as
opposed to patient cost-sharing), affects treatment choices, clinical practice, and health outcomes for the elderly.
The research outlined in this proposal aims to start filling this gap. The project investigates how the presence or
lack of insurance coverage for specific procedural or pharmacologic therapies affects treatment decisions and
health outcomes for the elderly with Alzheimer’s Disease and related Dementias (ADRD). This is a population
that may be particularly vulnerable to changes and limits in insurance coverage, as the patients may have limited
decision-making capacity and may be disproportionately exposed to treatments that are deemed experimental
and lacking effectiveness to clear the “reasonable and necessary” threshold. Aim 1 of the project is to estimate
the average effect of coverage decisions across prescription drugs and outpatient procedures on treatment
decisions and health outcomes of elderly Medicare enrollees with ADRD. Aim 2 is to predict and characterize
the subgroups of ADRD patients that are most likely to be affected by decisions that restrict the scope of
insurance coverage using machine learning methods. The proposed empirical method is to use quasi-
experimental variation that arises from natural experiments of abrupt changes in insurance coverage within
different parts of the Medicare program. The analysis takes advantage of variation in the scope of formularies
across Medicare Part D plans, as well as the variation in local coverage decisions for physician services and
outpatient procedures under Medicare Part B. These sources of variation coupled with methods for quasi-
experimental estimation of treatment effects and machine learning methods for heterogeneity analyses, allow
estimating the response of treatment decisions and health of the elderly with ADRD across different drugs,
procedures, and subgroups of ADRD patients.

Public health relevance
PROJECT NARRATIVE For elderly Americans, who benefit from nearly universal coverage under Medicare, decisions about the scope of their insurance coverage have been a central policy concern since Medicare’s inception in 1965 - Medicare’s coverage is extensive, but nevertheless incomplete as by statute the program only covers medical services that are “reasonable and necessary,” which can be hard to define. The debate around the scope of Medicare coverage is likely to intensify in the coming decades as options for medical treatment, and testing, expand rapidly, the population ages, and public insurance systems grapple with how to address inequality in access to medical innovations. In this project I investigate how changes in coverage for prescription drugs, physician office visits, and outpatient procedures affect the treatment received by elderly patients with Alzheimer’s Disease and related dementias (ADRD), who often face coverage limitations due to experimental nature of many ADRD treatments, and yet may be most vulnerable to unintended consequences of any coverage restrictions.